2023 Tissue Microstructure Imaging Gordon Research Conference and Gordon Research Seminar

Project Summary
This application requests support for the second Gordon Research Conference (GRC) on Tissue
Microstructure Imaging. The goal of this biannual GRC is to provide a one-of-a-kind forum for scientific
exchange among researchers focusing on characterizing cellular and sub-cellular biological tissue structure
using bio/medical imaging methods such as Magnetic Resonance Imaging (MRI), Ultrasound, X-ray, Optics,
Photoacoustics, and other modalities.
The topic of the 2023 meeting will be Developing Synergies Between Microstructure Imaging Modalities.
This GRC will cover an array of topics spanning the use of imaging in cells, animals, and humans, and will
address both fundamental questions and clinical applications.
The objectives of the meeting are:
1.
2.
Fundamental: To offer a unifying outlook at the tissue microstructure based on complementary vantage
points, and to stimulate cross-pollination and validation of different techniques, models and analysis tools.
Practical: To compare different imaging methods from the point of providing accurate assessment of tissue
structure, function, pathological/development/age changes, and response to treatment.
3. Social: To cultivate a cross-disciplinary imaging community, and to present unpublished findings, discuss,
and foster collaborations between established and young investigators across imaging modalities.
The conference will include nine scientific sessions (each with two to three speakers and a discussion leader),
poster sessions and discussions designed to facilitate close interaction between the participants. By design,
GRC meetings are small by conventional standards, but participants will be recruited in a manner to encourage
and ensure attendance by a diverse group of junior and senior investigators representing academic and
government institutions and individuals from corporate research programs. Students and postdoctoral fellows
will be encouraged to attend. Junior investigators will be included in the oral presentations. The support
requested herein will be used to facilitate the attendance (conference fees) of junior investigators, women,
minorities, and the disabled. No NIH funds will be used to support the direct charges for food and beverages.
The 2023 GRC will be held July 16-21, 2023, at Stonehill College, Easton, MA. The Chair is Dmitry
Novikov, PhD, from NYU School of Medicine, an expert in microstructure MRI. The Vice-Chair is Olivier
Couture, PhD, from the Sorbonne, France, a pioneer of super-resolution ultrasound. To promote the
participation and professional development of students and postdoctoral fellows, the GRC will incorporate a
Gordon Research Seminar (GRS) immediately prior to the conference (July 15-16) organized by trainees
(Santiago Coelho, PhD and Georges Chabouh, PhD). This multifaceted program will provide opportunities for
scientists at all levels and promote the participation of junior investigators, students, postdoctoral scholars and
newcomers to the field.

Public health relevance
Project Narrative The second Tissue Microstructure Imaging Gordon Research Conference (July 16-21, 2023), and the related Gordon Research Seminar (July 15-16, 2023) is a response to the growing interest in probing changes in tissue microstructure, for studying fundamental physiology, development, aging and pathology, for designing diagnostic markers of diseases, and for quantifying treatment response to various therapies. The 2023 meeting will solidify the diverse community of researchers from different imaging modalities (such as ultrasound, MRI, X-ray, photoacoustics and super-resolution microscopy), and is aimed at discussing unresolved problems, and designing synergistic approaches and cross-validation methods.